A pilot study of time-restricted eating among pregnant females with severe obesity

ABSTRACT
In the United States, severe obesity (BMI ≥ 40.0 kg/m2) disproportionally affects non-Hispanic Black females of
reproductive age. Severe obesity is a significant predictor of adverse perinatal outcomes including gestational
diabetes mellitus (GDM), pre-eclampsia, premature birth, and at its most severe, fetal death, birth defects and a
three-fold greater risk of maternal mortality – outcomes that also disproportionately affect Black females.
Observational studies suggest weight maintenance and even modest body fat loss and altering the maternal
metabolic milieu (availability of glucose and lipids) in the gestational period may be important to reducing
perinatal health risks among pregnant females with severe obesity. Existing lifestyle interventions (calorie
control/dietary pattern changes/physical activity) have showed modest effects on attenuating excess gestational
weight gain and modest effects on perinatal health outcomes among pregnant females with obesity. Time-
restricted eating (TRE), where an individual simply watches the clock and consumes calories within a particular
eating window, is a simple and highly accessible eating pattern that has the potential to minimize gestational
weight gain, reduce excess glucose and lipids, and improve metabolic health among pregnant females with
severe obesity all of which could translate to improved perinatal health outcomes. Yet there are no clinical trials
of TRE in pregnancy. In response to PAS-20-160 - Small R01s for Clinical Trials Targeting Diseases within the
Mission of NIDDK, we aim to test the safety, feasibility, and acceptability of TRE among 60 pregnant Black
females with severe obesity. We will examine the preliminary efficacy of TRE (8-hr eating window in the 2nd
trimester & 10-hr eating window in the 3rd trimester) vs. Standard Care on safety, feasibility, and preliminary
efficacy on weight, cardiometabolic risk markers and perinatal health outcomes. The intervention will begin at
~16 weeks gestational age (GA) and continue through admission for labor and delivery. The study will involve
weekly meetings with a research team member, and research visits at baseline (~16 weeks GA), 25-27 weeks
GA and 35-37 weeks GA. Maternal and fetal health monitoring will occur weekly through a combination of
research specific assessments and clinical data collected during routine prenatal care and at labor and delivery
via patient electronic health records. The goal of our work is to reduce and prevent adverse perinatal outcomes
among pregnant Black females including those with severe obesity. In alignment with NIDDK’s mission, this
small-scale R01 study will provide the necessary data to accelerate the initiation of a full-scale efficacy trial of
TRE in pregnancy. Given the relative simplicity of TRE it can be easily disseminated in clinic demonstrating its
strong potential for wide-scale public health impact.

Public health relevance
NARRATIVE. Pregnant females with severe obesity are more likely to experience adverse perinatal health events including gestational diabetes, preeclampsia and preterm labor as well as birth babies with discordant growth patterns. Rigorous interventions targeting gestational weight gain and dietary quality have not translated to markedly improved perinatal health among this population suggesting a need for innovation. This pilot study aims to test the safety, acceptability and preliminary efficacy of time-restricted eating on weight, cardiometabolic risk markers and perinatal health outcomes among pregnant Black females given they suffer disproportionately from both severe obesity and adverse health events in the perinatal period.